NORTH CAROLINA--A RURAL MODEL FOR LIFE LONG TB EDUCATION

The TB Academic Award is a mechanism for achieving strong programs of TB education in targeted U.S. Medical Centers. The proposal from Duke University Medical Center demonstrates that our geographic region has an aggregate incidence of TB worthy of attention. Furthermore, we show that TB is a rural-based problem in North Carolina and propose educational programs more relevant to health care providers practicing in a largely rural region such as ours. Finally, we demonstrate that Duke has the infrastructure and commitment to develop and sustain a program of TB education. We believe such a program could serve as a model for states with similar population patterns, healthcare shortages, and incidence of TB. Our goals for the TB academic award at Duke are: a) to improve existing Duke curricula so that clinical trainees at Duke Medical Center will, upon completion of their training: know how to prevent, manage and control TB; know specifically where to turn for continued medical education about TB during their professional lives; and understand the role of local health departments in the management of TB infection and disease; b) to develop curricula and educational interventions that can be customized and used in similar regions of the U.S; c) to improve Duke's effectiveness in teaching practicing clinicians about TB in our region and provide them with effective life- long educational resources; d) to use the coordinated and interdepartmental nature of this educational initiative to improve the care of TB patients at Duke by establishing consistent diagnostic and therapeutic practices; e) to develop and teach computer-based distance learning modalities that are versatile, simple to update and can be integrated into currently developing curricula and strategies.